Spousal dementia caregivers: Risk for accelerated aging

PROJECT SUMMARY
No changes from parent grant. See Supplement Research Plan for supplement specific information.

Public health relevance
PROJECT NARRATIVE No changes from parent grant. See Supplement Research Plan for supplement specific information.